Environmental Exposures, Reproductive Windows, and Social Drivers of Young-Onset Breast Cancer

PROJECT SUMMARY
Young-onset breast cancer (YOBC), diagnosed in women <50 years old, is increasing in incidence by 1-2%
annually in the U.S. and is associated with worse outcomes compared to breast cancer (BC) diagnosed
later in life. Most YOBC cases occur in women without inherited genetic risk, highlighting the need to better
understand environmental, reproductive, and social drivers of the disease. Emerging evidence suggests
that exposures during vulnerable life stages such as puberty, pregnancy, and the postpartum period may
have lasting effects on BC risk. Concurrent shifts in reproductive timing (e.g., delayed childbirth) and rising
environmental exposures (e.g., air pollution, pesticides, ‘forever chemicals’ in water, lack of greenspace
access) may contribute to this trend, particularly in socially disadvantaged populations. Methods: We will
conduct a population-based, matched case-control study using data from the Healthy Oregon Project
(HOP), a mobile health research platform with >50,000 participants statewide. YOBC cases (n=600) and
age and race-matched controls (n=1,200) identified from the HOP will complete detailed surveys on
reproductive history (e.g., age at menarche, parity, age at first/last birth, lactation); residential addresses
and age/year at key life stages: (1) menarche, (2) each pregnancy and postpartum period, and (3) pre-
diagnosis window for cases and a matched age window for controls, and current period; and social factors
(e.g., education, healthcare access). Geocoded residential addresses will be linked to environmental
datasets on PM2.5, pesticides, agricultural and urban greenspace, and PFAS to quantify environmental
exposures during each key reproductive time window and pre-diagnosis window (cases) or current period
(controls). Specific Aims: We propose to: 1) Evaluate the effects of environmental exposure mixtures
during key reproductive life stages using quantile g-computation. This approach will allow us to assess the
cumulative/overall impact of environmental exposure mixtures and the relative contribution of individual
environmental exposure component at each time window on YOBC risk. We will compare the magnitude
and direction of environmental [mixture] risk estimates between reproductive life stages and the pre-
diagnosis period to identify the most critical window of vulnerability; 2) Determine how social drivers
influence YOBC risk via environmental exposures and reproductive factors using structural equation
modeling (SEM). We hypothesize that environmental exposures during hormonally sensitive life stages
interact synergistically with reproductive timing to increase YOBC risk, with a prediction that earlier life
exposures playing the most significant role, and that social disadvantage amplifies these risks. This study
will identify modifiable, time-sensitive environmental exposures and provide insight into how social and
reproductive factors may compound these risks, informing future YOBC prevention strategies, particularly
among socioeconomically and environmentally vulnerable populations.

Public health relevance
PROJECT NARRATIVE Young-onset breast cancer (YOBC), diagnosed in women under 50, is increasing by 1–2% annually in the U.S., and concurrent trends, including delayed childbirth and increasing adverse environmental exposures (e.g., PM2.5, pesticides, PFAS in water, lack of greenspace access) may contribute to the rise, particularly in socially disadvantaged populations. Emerging evidence suggests that adverse environmental exposures during key reproductive windows may disrupt endocrine signaling, immune regulation, and inflammatory and cell proliferation pathways in the breast, with lasting effects on breast cancer risk. The purpose of this research is to determine how cumulative environmental exposures and the relative contribution of individual components during these critical reproductive windows influence YOBC risk, and how social factors compound these risks, using a population-based matched case-control study (n=600 cases and n=1200 controls), leveraging the statewide Healthy Oregon Project (HOP) cohort of over 50,000 individuals, to inform targeted time-sensitive prevention strategies.